Buffalo Research Innovation in Genomic and Healthcare Technology (BRIGHT) Short-Term Training and Education

ABSTRACT
Biomedical Informatics is an inherently interdisciplinary field of study that requires researchers to have a
knowledge base in numerous domains, including: biology, medicine, public health, ontology, human factors,
and data science. This multidisciplinary nature presents as a barrier to precocious students who may have an
interest in Biomedical Informatics but lack the prerequisite foundational skills and knowledge. We aim to
reduce that barrier to entry with our proposed research education program by equipping undergraduate and
master’s students with the skills to enable them to begin their career via graduate education or workforce
employment. At the same time, we need a special focus on increasing excellence through diversity. The
percentage of URMs is low when compared with other disciplines and this needs to be corrected if we are to
reach our excellence goals.
We propose a 12-week Buffalo Research Innovation in Genomic and Healthcare Technology (BRIGHT)
short-term training and education program at the University at Buffalo’s Jacobs School of Medicine and
Biomedical Sciences in the Department of Biomedical Informatics. Every year this program will host 12 top
undergraduate and master’s candidates for intensive training in Biomedical Informatics and Data Science
involving didactics, hands-on research, and career development activities. Our overall objective is to recruit
and train diverse undergraduate and masters’ students to prepare them for future careers in
Biomedical Informatics and Data Science. We will accomplish this objective through the following aims:
Aim 1: Expand trainee’s knowledge base in Biomedical Informatics and Data Science via didactic
teaching, including lectures and interactive notebooks.
Aim 2: Provide trainees with hands-on research in Biomedical Informatics to develop useful
computational and statistical skills and career development opportunities to prepare trainees for
educational programs and future careers in Biomedical Informatics research.
Aim 3: Improve outreach programs to increase recruitment of URM trainees to promote diversity in
Biomedical Informatics and Data Science educational programs and research careers.
The University at Buffalo’s Department of Biomedical Informatics is excited to provide the Buffalo Research
Innovation in Genomic and Healthcare Technology (BRIGHT) short-term training and education
program to enable research experiences to attract diverse, talented students to biomedical/data science
careers. Furthermore, we will enhance diversity in biomedical informatics research, health, and healthcare by
fostering the next generation of innovative URM researchers who will and are making essential contributions to
Biomedical Informatics and Data Science.

Public health relevance
NARRATIVE We propose a 12-week Buffalo Research Innovation in Genomic and Healthcare Technology (BRIGHT) short-term training and education program at the University at Buffalo’s Jacobs School of Medicine and Biomedical Sciences in the Department of Biomedical Informatics. Every year this program will host 12 top undergraduate and master’s candidates for intensive training in Biomedical Informatics and Data Science involving didactics, hands-on research, and career development activities. Our overall objective is to recruit and train diverse undergraduate and masters’ students to prepare them for future careers in Biomedical Informatics and Data Science.